Investigating essential chromatin regulators in cancers with SWI/SNF mutations

PROJECT SUMMARY
Genes that encode subunits of SWI/SNF chromatin remodeling complexes are mutated in nearly 25% of cancers.
Additionally, germline mutations in SWI/SNF subunits cause several neurodevelopmental disorders. However,
the mechanisms by which these mutations drive cancer and disease are poorly understood. SWI/SNF
complexes mobilize nucleosomes at enhancers and promoters to modulate transcription. Biallelic inactivation of
SMARCB1, a gene encoding a SWI/SNF complex subunit, causes pediatric rhabdoid tumors (RTs). These highly
aggressive soft tissue tumors occur in infants and young children and have extremely poor outcomes. Since RT
genomes are diploid and lack other mutations, they are ideal for studying SWI/SNF-specific mechanisms driving
cancer and for identifying novel therapeutic targets. My mentor and his collaborators initiated the Pediatric
Cancer Dependency Project to identify novel drivers and therapeutic targets in pediatric cancers, including RT.
Performing genome-wide CRISPR screens in 10 RT cell lines compared to over 800 other cancer cell lines
revealed a novel gene that SMARCB1-deficient RT specifically depend upon for survival. This proposal seeks
to investigate the function of this putative chromatin regulator and to determine why it constitutes a
specific dependency in RT. Overexpression of this gene is associated with poor prognosis in several cancers
and thus pharmacological efforts are already underway to develop chemical inhibitors. Intriguingly, preliminary
experiments suggest that this protein may control histone post-translational modifications (PTMs) that dictate
remodeling by SWI/SNF complexes and gene expression. Understanding why RT cells depend on this protein
for survival will reveal novel mechanisms of chromatin regulation and may identify a new therapeutic target in
these lethal cancers. My central hypothesis is that this protein controls histone PTMs and is required for
the chromatin recruitment of the sole family of SWI/SNF complexes that lack SMARCB1, thus making it
essential in RT. This proposal will investigate how this regulator, which lacks enzymatic activity, controls these
histone PTMs and how this influences chromatin accessibility. Additionally, it will determine how this regulator
influences remodeling and gene expression controlled by SWI/SNF complexes. Collectively, this proposal will
uncover the function of this relatively understudied protein, provide novel insight into how chromatin function is
regulated, explain why RTs selectively depend on this protein for survival, and potentially identify a novel
therapeutic target in the lethal pediatric rhabdoid tumor. Additionally, this proposal is designed to address my
training goal of becoming proficient in studying chromatin biology both experimentally and computationally.

Public health relevance
PROJECT NARRATIVE Nearly 25% of all pediatric and adult cancers have damaging mutations in the genes that encode SWI/SNF chromatin remodeling complex subunits, but our understanding of how these mutations cause cancer is quite limited. This proposal investigates a relatively understudied gene that aggressive pediatric cancers with mutations in this complex depend on for survival. Collectively, these studies will offer insight into how damaging mutations in this complex cause cancer, reveal new ways chromatin function is regulated, and potentially identify a new therapeutic target in this aggressive pediatric cancer.